Targeting PD-L1 interactome signaling to enhance immunotherapy efficacy in head and neck squamous cell cancer

SUMMARY. The programmed death receptor 1 (PD-1) drives immune escape in head and neck squamous cell
cancer (HNSCC), whose incidence is rising due to human papillomavirus (HPV). Inhibitors of PD-1 (PD-1i) in T
cells, or its ligand in cancer cells (PD-L1i), are in use in many cancers including recurrent/metastatic (R/M)
HSNCC, but most patients do not respond. While the PD-L1 extracellular domain (ECD) is a ligand mediating T-
cell anergy, the intracellular domain (ICD) role is less known. We found that PD-L1 over-expression increased
key pro-tumorigenic properties. ICD deletion disrupted this signaling and reversed the pro-growth features. We
hypothesized that PD-L1 ICD interacts with intracellular proteins, and to define the PD-L1 interactome we used
a proximity-dependent labeling assay to measure interacting proteins with/without PD-1 binding. The PD-L1
interactome was consistent across cell lines, and top partners included nuclear factor of activated T cells (NFAT)
subunits interleukin enhancer-binding factor 2 and 3 (ILF2/ILF3), that stabilized the signal transducer and
activator of transcription 3 (STAT3) to induce pro-growth properties. In humanized mouse models of HPV+ and
HPV- HNSCC, PD-1 binding induced PD-L1 signaling, and combined PD-L1i and STAT3 inhibitors (STAT3i)
were required to achieve durable tumor control. In sum, PD-1 binding to PD-L1 led to an elegantly coordinated
effect of simultaneous immune evasion and tumor progression, the latter driven by STAT3. In this project we will
study the full spectrum of the PD-L1 interactome in HNSCC from its mechanistic basis to in vivo validation, and
then patient clinical testing. First, we will identify the ICD precise domain responsible for the PD-L1 interactions
with its cytoplasmic targets, by deploying HNSCC (and melanoma as control) cell lines with a set of mutated ICD
constructs on a PD-L1 knockout by CRISPR/Cas9 backbone. PD-L1 interactome and signaling disruption will be
assessed by changes in intrinsic and extrinsic properties. This will be followed by structural modelling and
analyses of PD-L1 interactions that will enable discovering pharmacological disruptors. Secondly, we will test
the role of STAT3 signaling in PD-1i response in a HNSCC humanized model with patient-matched, autologous
thymic education capability. To elucidate complex immune events, in vivo testing is key, and to be relevant,
mouse models need to be able to elicit a true, immune-based antitumor response. Thirdly, we will conduct a
proof-of-concept trial of the STAT3i NT219 combined with the approved PD-1i pembrolizumab in PD-1i-naïve
HNSCC patients. The planned immuno/pharmacodynamic and efficacy testing will explore if combined therapy
increments response, and if baseline parameters including STAT3 signaling expression predict efficacy, setting
the stage for practice-changing trials. The notion that the PD-1:PD-L1 axis, the most validated checkpoint
inhibitor pathway in human cancer, is a bi-directional and synchronized process rather than a simple ligand-
receptor step is a paradigm shift. By understanding canonical PD-L1 signaling and the coordinated role of the
PD-L1:PD-1 interaction we will unlock the full potential of immune modulation as an anticancer therapy.

Public health relevance
NARRATIVE. Major limitations in understanding the cancer-host interaction and in finding drugs that will help stop cancer progression include either simply culturing cancer cells on plastic dishes or injecting cells on mice that have no human immunity. We have discovered new roles of a protein thought to be just an immune ligand mediator called PD-L1 and uncovered a coordinated strategy initiated by this protein that leads to not only the known evasion from the immune system, but also independent promotion of tumor growth. In this application we plan to investigate and characterize both roles and how they interact and can be targeted to improve anticancer therapy efficacy.